Core H: Retrovirology and Molecular Data Science

Abstract
The overarching goal of the Retrovirology and Molecular Data Sciences Core (RMDSC) is to lift barriers to
performing optimized experiments focused on viral analysis, and analyzing data from state-of-the-art genomics
and database technologies for HIV research. Our aims reflect the continuing evolution of the technologies
associated with viral genetic analyses that have been a mainstay of our Core for the past 20+ years. In this
realm we are adding state-of-the-art consultation in all modern DNA sequencing platforms. These include the
emerging Pacific Biosciences platform, which is being led by early career investigator Dr. Ben Murrell, who has
unsurpassed experience with their technology. Dr. Joshua Herbeck, Core Associate Director, will provide
leading expertise in phylodynamic and molecular epidemiology studies, of great importance to modern
transmission intervention approaches. In addition, we propose to further develop our genomics-focused data
tracking and analysis database for distribution, as well as assist other laboratory-based investigators with the
same. Importantly, we are also adding three new realms of support from our core: the conduct of state-of-the-
art virologic methodologies; access to a unique specimen database from individuals enrolled during
primary/early HIV infection; and development and provision of database and analytical tools to the wider CFAR
community. We have and will further enhance strong interconnections with multiple other CFAR cores and
SWGs within the UW/Fred Hutch CFAR and other CFARs in order to extend the unique value of our resources
to the HIV/AIDS research community worldwide. We propose the following four specific aims: Aim 1. To
CONSULT with investigators on experimental design, optimal specimen acquisition, collection and processing,
clinical trial development, data processing, and data interpretation, with a focus on experiments that acquire
molecular sequence data. Aim 2. To PROVIDE specimens and access to state-of-the-art sequencing
technologies. Aim 3. To DEVELOP new software tools, databases and custom applications for bench support,
data management, and visualization across a wide spectrum of bench science based CFAR activities. Aim 4:
To TRAIN investigators in experimental design and safeguards, and computational skills and literacy.